The role of enteric glia in visceral hypersensitivity

PROJECT SUMMARY
The proposed training and research plans are focused on developing the Applicant’s expertise in enteric
neuroscience and pain signaling. To this end, the training plan focuses on a mix of comprehensive technical
research and career development training with the goal of providing the Applicant a complete set of skills
necessary to develop into an independent scientist. The research plan complements the training experience by
investigating mechanisms whereby enteric glia regulate the activity of visceral nociceptive neurons. The
proposed research will test the central hypothesis that enteric glia promote nociceptor hypersensitivity during
acute inflammation through mechanisms that include connexin 43-dependent release of prostaglandin E2
(PGE2), the regulation of monoglyceride lipase (MAGL), and sensitization of transient-receptor potential
vanilloid-1 (TRPV1) channels in nociceptive nerve terminals. This hypothesis will be tested in two Specific Aims
that utilize advanced dual chemo- and optogenetic reporter systems in mice, advanced cellular imaging assays,
and whole animal models. Aim 1 will study enteric glial mechanisms that modulate nociceptor activity during
acute inflammation through connexin 43-dependent PGE2 release. Aim 2 will study how glial MAGL contributes
to nociceptor sensitization during acute inflammation. The applicant will develop knowledge in cellular imaging,
enteric neurobiology, and pain signaling through hands-on research, coursework, and expert mentorship. The
major impact of the proposed research and training is to provide a significant enhancement of the applicant’s
expertise in cutting-edge skills and technologies in neuroscience and physiology, while simultaneously defining
novel mechanism that contribute to visceral pain that will contribute to the advancement of novel therapies.

Public health relevance
PROJECT NARRATIVE Abdominal pain is the most common gastrointestinal issue and is caused by the sensitization of sensory nerve fibers that innervate the gastrointestinal tract. Why this occurs is not understood; this proposal studies how a class of non-neuronal cells called enteric glial regulate the sensitivity of nerve fibers innervating the intestine. Understanding the mechanisms by which glia regulate nerve fiber sensitivity will identify new therapeutic targets to improve abdominal pain.